Prenatal Fatty Acid Supplementation and Early Childhood Asthma and Atopy in Black American Families

Project Summary
Asthma is a chronic inflammatory lung disease that currently affects an estimated 8.4% of children in the U.S.,
resulting in over 600,000 emergency department visits and over 75,000 hospitalizations each year (Moorman et al.,
2012). For decades the burden of asthma in the U.S. has fallen disproportionately on Black children living in low-
resourced communities, for whom the prevalence, morbidity and mortality rates far exceed those for White
children. Black children have 2-3 times higher rates of hospitalization and emergency department visits compared
with White children, and a nearly 5-fold increase in asthma-related mortality (Volerman, et al., 2019). In some
neighborhoods on the South Side of Chicago the rates of asthma among young Black children are over 40% (Gupta et
al., 2008). The high rate of asthma and allergy in Black children appears to be in part influenced by prenatal stress
exposure. Thus, an intervention designed to improve prenatal stress regulation in Black women may also reduce the
risk of asthma in their children. The Nutrition and Pregnancy Study (NAPS) (NCT02647723) is a nearly completed
double-blind, randomized controlled study (RCT) of prenatal fatty acid supplementation aiming to improve birth
outcomes and infant neurodevelopment via improved prenatal stress regulation. Docosahexaenoic acid (DHA), an
omega-3 fatty acid, has been shown to protect against the development of asthma and atopy in controlled animal
studies and in observational studies of humans. Results from two small RCTs of infant formula supplementation
provide further support for the protective effects of dietary fatty acids against asthma (Birch et al., 2010; Foiles et
al., 2016). The NAPS study provides an unprecedented opportunity to test the effects of prenatal DHA levels on
childhood asthma and atopic disease, and to further examine how patterns of prenatal stress regulation impact that
effect. We propose to conduct clinical assessments of asthma and other atopic outcomes in 130 children at 5-6
years of age whose mothers participated in the NAPS study, and to collect data from medical records and maternal
report to test two aims. Aim 1: Test whether prenatal fatty acid levels are associated with asthma and atopic disease
in early childhood. We hypothesize that higher prenatal blood levels of DHA will be associated with lower levels of
asthma and atopy in the offspring as measured via laboratory assessments of asthma and allergic sensitization at
ages 5-6 years, as well as medical record abstraction and maternal report. Aim 2: Test whether prenatal stress
regulation impacts the association between prenatal fatty acid levels and asthma and atopic disease in early
childhood. Our primary hypothesis is that cortisol and cytokine levels, heart rate variability, and perceived stress
during pregnancy will partially mediate the association between prenatal DHA levels and childhood asthma and
atopic disease. We will also test whether the association between prenatal DHA levels and early childhood asthma
and atopic disease is moderated by prenatal stress regulation at baseline and by changes in stress regulation during
pregnancy. To our knowledge, this will be the first test of prenatal fatty acid levels on asthma and allergy in Black
children living in low-resourced environments in the U.S.

Public health relevance
Project Narrative The goals of the proposed study are to test whether fatty acid supplementation to the diet during pregnancy reduces the risk for asthma and allergic disease in children at ages 5-6 years. The burden of asthma in the U.S. has fallen disproportionately on Black children living in low-resourced communities, for whom the prevalence, morbidity and mortality rates far exceeds those for White children. To our knowledge, this will be the first test of prenatal fatty acid levels on asthma and allergy in Black children living in low-resourced environments in the U.S.